Network drivers of regional vulnerability to early Alzheimer's disease pathology

Project Summary
Post-mortem and in-vivo neuroimaging studies have shown that beta-amyloid (Aβ) and tau pathology
are associated with neurodegeneration and cognitive decline in typical aging and Alzheimer’s disease (AD).
Though previous work suggests that Aβ plays a role in driving tau pathology spread and that this interaction is
key to the development of AD, Aβ accumulates multifocally across the neocortex whereas tau deposits in the
medial temporal lobe and spreads in stereotyped patterns to highly connected cortical projections. Given the
spatiotemporal differences of Aβ and tau accumulation, it is unclear how these two pathological proteins
remotely interact, especially in the earliest stages of disease, to promote regional vulnerability to further protein
accumulation underlying aging and AD. Previous studies have identified distinct intrinsic brain networks and
functional connectivity patterns associated with early AD pathology deposition and spread, suggesting
vulnerability to AD pathology and subsequent spread may be dependent on brain activity. The current project
will use positron emission tomography (PET) imaging and resting-state fMRI (rsfMRI) to investigate
mechanisms of Aβ and tau interactions via functional networks. The goal of this study is to examine how
network connectivity is associated with AD risk, longitudinal pathology accumulation, and aging. Aim 1 will use
regions of early AD pathology deposition identified in older adult (OA) PET scans as seeds to construct Aβ and
tau-seeded functional networks in young adult (YA) rsfMRI data. Then, functional network connectivity between
early Aβ and tau-seeded networks will be examined in relation to AD risk (APOEε4) in YA. Aim 2 will apply the
networks constructed in Aim1 to OA rsfMRI data and investigate how network connectivity of early Aβ and tau-
seeded networks is related to longitudinal AD pathology accumulation measured by PET imaging. Aim 3 will
explore how properties of Ab and tau-seeded networks change with age and how these age-related changes
are associated AD pathology accumulation and cognitive decline in OA. Overall, this proposal will allow the
applicant to develop skills in: (1) acquisition and advanced analysis of multimodal neuroimaging data, (2)
statistics and data analysis, (3) clinical impairment and pathophysiology of AD, (4) science communication, and
(5) teaching and mentorship. The UC Berkeley Helen Wills Neuroscience Institute is at the forefront of cutting-
edge research and provides access to world-class facilities and experts in neuroimaging, cognitive
neuroscience, and biostatistics, which will support the applicant in the completion of this project and training
plan. The sponsor, Dr. William Jagust, is an expert in using multimodal neuroimaging to investigate aging and
AD and is uniquely suited to oversee the proposed project and training plan. He has successfully mentored
many trainees who are now leaders in the field. The proposed research and training plan will provide the
applicant with critical skills necessary to attain a competitive post-doctoral fellowship and excel as a future
independent researcher in the aging and AD fields.

Public health relevance
Project Narrative The proposed project will investigate how functional connectivity between networks that harbor early Alzheimer’s disease (AD) pathology are related to AD risk, longitudinal AD pathology accumulation, and age. Although the co-occurrence of Aβ and tau pathology underlie AD, the mechanisms by which early forms of these proteins interact across spatially distant brain regions to promote AD progression are not well understood. Functional network connectivity may underlie these remote interactions and this project will provide insight into mechanisms that drive regional vulnerability to early pathological protein accumulation in aging and AD.